The role of cis-regulatory elements in the inheritance of transcriptional memory through mitosis.

PROJECT SUMMARY
The goal of this proposal is to determine how cell identity, as defined by a transcriptional program, is
inherited through mitosis by systematically evaluating the role of specific cis-regulatory elements and trans-
acting factors. The central hypothesis is that cis-regulatory elements at gene promoters maintain transcriptional
competency through mitosis while trans interactions with enhancers mediate the timely and appropriate level of
gene expression during mitotic exit. This proposal will leverage how the underlying DNA sequence determines
the multifaceted interactions at promoters and cell-type specific enhancers that ensure cells faithfully re-
establish proper transcriptional programs. This will be evaluated in cells with a stable identity and expanded to
understand how this is mediated in the context of early development, when cells undergo constant fate
decisions. While it was previously thought that chromatin condensation during mitosis excluded most proteins
and thereby transcription-related processes, recent studies originally emanating from the Zaret lab now
indicate that transcription is active at a low level and promoters, but not most enhancers, are accessible and
maintain active histone modifications [1-7]; and mitotic chromatin arms retain areas of dynamic chromatin [8].
Although genome-wide measurements of histone modifications, chromatin accessibility and chromatin
organization suggest mitotic changes at various cis-regulatory elements, they are unable to garner high-
resolution mechanistic insight into how mitotic memory is retained at promoters and acted upon, during mitotic
exit, by enhancers. While components involved in transcription such as the TATA-binding protein TBP, the
elongating form of RNAP2, and transcription factors (TFs) such as GATA1, FOXA1, and ESRRB are detected
on mitotic chromatin; many of these TFs do not remain bound to their interphase enhancer targets, thus how
these factors function at specific loci to transmit transcription memory through mitosis remains elusive [5-7, 9-
13]. Therefore, this proposal aims to determine how cell fate is preserved through cell division by first
evaluating the functional requirement for promoters in mitotic transcription, and then the mechanisms
employed by liver-specific transcription factors to mediate enhancer activation upon mitotic exit. This will be
assessed in the liver-derived HUH7 human cell line, which is highly amenable to mitotic synchronization
methods, and expanded to determine the role of identified factors in pluripotent and endoderm-differentiated
human embryonic stem cells. This proposal will expand our understanding of the molecular mechanisms that
maintain cell identity and cell fate specification, thereby improving our ability to target and modulate stem cells
for therapeutic value.

Public health relevance
Project Narrative Mitosis is a pivotal point during which a cell divides and gives rise to two genetically identical daughter cells. However, transcriptional programs must also be transmitted to ensure cell identity is properly re-established with each cell division. This proposal will study the molecular mechanisms that allow cells to maintain and faithfully re-establish the proper magnitude of gene expression through mitosis towards understanding how cell fate and identity is encoded.